Exploring Virtual Reality Mindfulness Training for Veterans with SCI and Chronic Pain.

1 Background and Significance: An estimated 70% of individuals with SCI struggle with chronic pain, which
2 negatively impacts quality of life, satisfaction, and social participation. Virtual care and the use of innovative
3 technologies like virtual reality provide engaging and effective ways to expand access to care and improve health
4 and well-being. However, as virtual care expands, research involving the use of virtual modalities in the SCI
5 population lags behind other populations. Additionally, most virtual evidence-based behavioral interventions for
6 chronic pain are designed for nondisabled populations, creating potential accessibility barriers in program
7 procedure and content fit that likely impact intervention acceptability in individuals with SCI. One tool used to
8 combat chronic pain is mindfulness, which is the practice of being aware of the present moment in a sustained,
9 accepting, and nonjudgmental way. Mindfulness can reduce anxiety and depression, which are associated with
10 greater pain intensity. Low mindfulness is linked to pain catastrophizing, which increases avoidance of activities
11 that may provoke pain, thereby decreasing overall function and participation (ie, pain interference). Pain
12 interference moderates the impact of pain on quality of life and social participation, whereas using mindfulness
13 to increase pain acceptance results in better function, social participation and quality of life. The VA
14 Compassionate Awareness Learning Module (VA CALM) teaches Veterans the powerful skill of mindfulness. VA
15 CALM delivers content in a weekly group setting, providing an optimal solution for Veterans with SCI and chronic
16 pain. The group structure benefits self-efficacy and social participation by providing a space to normalize
17 experiences and promote connectedness, which is particularly important for individuals who have limited
18 community mobility and interactions with SCI peers. However, given the complexities of neurological injury,
19 individuals with SCI have alterations in sensation, motor control and proprioception. Although mindfulness has
20 demonstrated major benefits, mindfulness activities are often designed for “neurologically normative” populations
21 without consideration/accommodation for those with neurologic alterations, resulting in low acceptability and
22 content mismatch. Mindfulness and VR are 2 solutions gaining traction in chronic pain research, but there is
23 limited research leveraging these combined approaches in the SCI population and further research is necessary.
24 Evidence demonstrates that VR improves embodiment among patients with neuropathic pain. Embodiment, an
25 essential element of mindfulness, is the concept of awareness and attention to the body in relation to situation
26 and environment. VR modalities provide engaging, low-cost solutions that are customizable, which is ideal for
27 the accessibility needs of the SCI population. Research Plan: Aim 1: Conduct formative evaluation of the VA
28 CALM program to develop accommodations to improve accessibility for Veterans with SCI. VA CALM will be
29 delivered to 10 Veterans with SCI to assess for needed modifications to adapt the program for SCI. A steering
30 committee of 10 members (including clinicians, researchers, and Veterans with SCI) will meet during content
31 redesign meetings to determine appropriate accommodations. Aim 2: Explore the feasibility and acceptability of
32 delivering VA CALM over a virtual reality platform for Veterans with SCI. This will be achieved by delivering 2
33 modified modules via VR to Veterans with SCI assess the feasibility and acceptability of using VR to deliver this
34 program. Veterans will complete quantitative surveys and qualitative focus groups to provide detailed information
35 about feasibility and acceptability of both the modified program and the use of VR for program delivery in the
36 SCI population. Career Plan: Dr. Touchett will receive training in rehabilitation research to gain proficiency in
37 participatory research methods, user experience and accessible design, and research design, grantsmanship,
38 and scientific writing. These objectives will be achieved through mentorship, formal courses, and other trainings.
39 The CDA-1 Award will allow her to become a nurse scientist who adapts and implements innovative virtual
40 behavioral health treatments that are optimized for Veterans with SCI.

Public health relevance
1 Quality of life, functional independence, and participation are essential considerations in the overall health and 2 well-being of Veterans with spinal cord injury (SCI). However, living with SCI is complex, often requiring ongoing 3 specialty healthcare to maximize health outcomes. Virtual care and the use of innovative technologies like virtual 4 reality (VR) provide engaging and effective ways to expand access to care and improve health and well-being. 5 However, as virtual care expands, research involving the use of virtual modalities in the SCI population lags 6 behind other populations. Mindfulness and VR are 2 solutions gaining traction in chronic pain research, but there 7 is limited research leveraging these tools in the SCI population and further research is necessary. This project 8 will deliver a mindfulness program to Veterans with SCI to evaluate modification needs and then convene a 9 Steering Committee of stakeholders to tailor for SCI. The project will then assess the feasibility and acceptability 10 of using VR to deliver mindfulness training among Veterans with SCI by delivering 2 modified modules via VR.